The role of dentate gyrus mossy cells in coordinating episodic memory formation and retrieval

PROJECT SUMMARY
In order to accurately store and retrieve memories, information about novel or salient experiences must be
flexibly integrated into existing memory networks while maintaining the stability of previously stored memories.
To accomplish these goals within the same circuit, the hippocampus must encode novel experiences and retrieve
neural representations of familiar ones in parallel. Disruption of this balance between encoding and retrieval may
underlie memory deficits observed in numerous neurological disorders that affect the hippocampus. The dentate
gyrus (DG) and CA3 subfields of the hippocampus are often considered to be essential for memory encoding
and retrieval, respectively. Encoding and retrieval in these regions rely on two complementary computational
processes, pattern separation and pattern completion. Pattern completion in CA3 allows for a full memory to be
retrieved despite incomplete inputs, while pattern separation in the DG prevents interference between similar
memories during encoding. Mossy cells, a relatively understudied DG cell type, occupy a key node in the DG/CA3
circuit and mediate communication between these areas. Mossy cells, which receive extensive neuromodulatory
inputs, may regulate DG/CA3 activity to enhance encoding of novel experiences and retrieval of familiar
experiences. The central hypothesis of this proposal is that mossy cells promote encoding of novel environments
by regulating the activity and neural computations of the DG/CA3 circuit. Technical limitations have prevented
extensive study of mossy cells in vivo, and it is unknown how exploration of novel environments affects DG/CA3
circuit dynamics. I will perform two-photon calcium imaging in the dorsal hippocampus of mice as they explore
novel and familiar virtual tracks to evaluate the role of mossy cells in encoding novel environments and regulating
DG and CA3 activity. In aim 1, I will directly record activity from mossy cells to determine how their spatial activity
differs in novel and familiar virtual environments. In aim 2, I will examine how mossy cells regulate communication
between the DG and CA3 by recording granule cell and CA3 pyramidal cell population dynamics while
optogenetically inhibiting mossy cell activity. Finally, in aim 3, I will generate a computational model of a
combined DG/CA3 circuit to directly examine how pattern separation and pattern completion within this circuit
are regulated by mossy cells. Understanding the neural basis of memory encoding and retrieval is an
instrumental step toward lessening the burden of memory impairments observed in numerous cognitive
disorders. The results of this proposal will provide fundamental insights into the role of mossy cells in regulating
these essential memory processes.

Public health relevance
NARRATIVE Numerous conditions that cause learning/memory impairments (e.g., Alzheimer’s, epilepsy, traumatic brain injury, post-traumatic stress disorder, schizophrenia, and stroke) affect the hippocampus, and the dentate gyrus specifically. Mossy cells, a commonly overlooked hippocampal cell type, regulate activity in the dentate gyrus and are particularly vulnerable to damage in many of these disorders. The proposed research will determine how mossy cells regulate the formation and retrieval of memories, offering new targets to treat memory impairments commonly observed in neurological disorders.